Cognitive Control of Emotion in Autism

DESCRIPTION (provided by applicant): This Mentored Research Scientist Development Award (K23) will enable the candidate to independently conduct research on the development of emotion regulation in autism that integrates clinical and brain findings. The candidate is a licensed child clinical psychologist, specialized in autism, who also has prior genetics training. Her short-term goals are to pursue training in the cognitive and affective neuroscience mechanisms underlying the development of emotion regulation in childhood and adolescence, the use of functional magnetic resonance imaging (fMRI), and methods for eliciting emotion and measuring emotional reactivity. Training will be accomplished via (a) meetings and guided readings with mentors Nancy Minshew, M.D., Kevin Pelphrey, Ph.D., and Ronald Dahl, M.D., and an expert team of internal and external consultants; (b) formal coursework; (c) attendance at local and national conferences, journal clubs, and research meetings, and (d) supervised hands-on experiences in the collection and analysis of data using fMRI methodologies and research on emotion regulation. The University of Pittsburgh School of Medicine and Carnegie Mellon University will be the primary sites of this training, offering a combination of excellence in neuroscience and psychiatric research. A key component of the training is participation in all aspects of the proposed study, which utilizes functional Magnetic Resonance Imaging to explore the cognitive control of emotion in ASD. This particular component of emotion regulation was chosen as the focus based on the applicant's clinical impressions that perseveration often leads to disruptive emotional meltdowns in ASD, and because research in other populations suggests that attentional biases related to emotion regulation may be highly amenable to treatment. Within the infrastructure of the Pittsburgh NIH Autism Center of Excellence (PI Minshew), the proposed research will include 120 12 to 18 year old children, with and without high-functioning autism/Asperger's. Participants will view fear-inducing and neutral film clips while in the scanner. Multiple methods will be used to capture emotional reactivity; most notably, participants will continuously rate their emotional status throughout their time in the scanner. The study aims to: characterize the role of perseveration in emotional responses to negative stimuli in autism; investigate the functioning of the amygdala and pre- frontal cortex, and their interactions, during emotional responses; and gather preliminary data on the impact of age and comorbid mood, anxiety, and inattention symptoms on individual differences in emotional responding in autism. Insights into emotion regulation gained from this study, and the skills that the applicant will attain through the related training, will place the applicant in a strong position to conduct research on emotion regulation in autism that will specify mechanisms of change to inform treatment development and explain varying response to treatment.

Public health relevance
PUBLIC HEALTH RELEVANCE: Poor emotion regulation in autism often leads to "meltdowns" and worsening of social functioning. This research will identify specific components of emotion regulation that are problematic in autism, and the underlying brain mechanisms related to these difficulties. This information can then be used to develop novel treatments to improve emotional and social functioning in autism. Relevance: Poor emotion regulation in autism often leads to "meltdowns" and worsening of social functioning. This research will identify specific components of emotion regulation that are problematic in autism, and the underlying brain mechanisms related to these difficulties. This information can then be used to develop novel treatments to improve emotional and social functioning in autism. __SpecificAimsTextDelimiter__ RESEARCH PLAN G. SPECIFIC AIMS While impairment in social interaction is considered the defining characteristic of autism, associated deficits in the perception, understanding, and expression of emotion have a devastating impact on daily functioning and quality of life. In addition, emotional and social functioning are inextricably linked, given that an ability to modulate emotional reactions is needed to meet environmental demands in a socially appropriate manner. Poor emotion regulation in autism and the absence of a vocabulary for effectively communicating about emotions often leads to "meltdowns" in the form of self-injury, aggression, worsening of repetitive behaviors, and general deterioration in functioning. Feelings of fear/anxiety in autism, in particular, have been linked to more negative and aggressive behaviors. Unfortunately, emotion regulation in autism is very poorly characterized from a behavioral perspective, and even less research has been done to identify the neural processes and associated characteristics that may play a role. Given this poor understanding of underlying mechanisms, treatment approaches for problems with emotion regulation in autism typically involve the use of multiple medications or hospitalization. Identifying specific components of emotion regulation that are altered in autism would lead to the development of targeted treatment strategies. One aspect that may be highly relevant in autism is the cognitive control of emotion. The tendency of children with autism to perseverate may interfere with their ability to shift attention away from stimuli that evoke negative emotional responses as a means of adaptive regulation. Problems with this type of cognitive control over attention to emotionally-provocative stimuli may be related to the reactivity of, and interactions between, the amygdala and prefrontal cortex. Furthermore, variability among children with autism in their ability to shift after experiencing a negative emotion may be due to age and comorbid mood, anxiety, and attention symptoms. This study will employ a multiple-methodology approach involving samples of 12- to 18-year-old children with and without high-functioning autism/Asperger's disorder (matched on gender, age, and IQ) to identify the mechanisms underlying emotion regulation deficits in autism spectrum disorders. G.1. Aim 1 To characterize the role of perseveration in emotional responses to negative stimuli in children with and without autism. Hypotheses: Children with autism will have greater difficulty shifting to a neutral emotional state after viewing negative emotionally-arousing stimuli (e.g. fear-inducing movie clips), compared to typically-developing children. This will be evidenced by prolonged self-report of greater negative emotion using continuous affect dials, after the negative stimulus has ended and the neutral stimulus has begun. It is expected this finding will correlate with parent- and self-report on measures of emotion and self-regulation, including a questionnaire scale designed to tap the ability to shift attention as a means of cognitive control of emotion G.2. Aim 2 To investigate the development of the underlying neural substrates for the cognitive control of responses to emotional information in children with and without autism. Hypotheses: Atypical patterns of development will be observed in autism in the functioning of the amygdala and prefrontal cortex, and their interaction, when viewing fear-inducing stimuli. The amygdala will remain activated longer in the autism group after the negative stimulus has ended and the neutral stimulus has begun. G.3. Aim 3 (Exploratory) To gather preliminary data on participant characteristics that may impact individual variability in emotional responding in autism. Exploratory Hypothesis: Age and level of comorbid mood, anxiety, and inattention symptoms will be significantly related to the intensity and duration of emotional response and amygdala and prefrontal cortex activation.